NRSA Training Grant in Quantitative Neuroscience

This proposal is for the renewal of a predoctoral and postdoctoral Quantitative Neuroscience Training Program
(QNTP) at Princeton University. Neuroscience research is becoming increasingly quantitative. Formal
theoretical techniques are essential for understanding how complex, large-scale interactions between neurons
give rise to thought and behavior, and advanced quantitative methods of data analysis are necessary for
addressing the increasingly large, multidimensional data sets generated by modern brain imaging techniques
(e.g., multiunit recording, fMRI). These methods are also necessary for future progress to be made in
understanding, diagnosing, treating and, ultimately, curing brain disturbances that give rise to psychiatric
disorders. Unfortunately, the mathematical and computational skills required to address these needs are not a
focus of standard neuroscience curricula. Princeton's QNTP is designed to address this need, by providing the
next generation of neuroscientists with the necessary mathematical and computational skills for measuring,
analyzing, and modeling brain function. The establishment of the QNTP sparked several developments at
Princeton, that (in turn) have accelerated the pace at which the goals of the QNTP are being met. By bringing
Princeton's neuroscientists together with faculty in Physics, Mathematics, Computer Science and Engineering,
the QNTP helped to spur the formation of the Princeton Neuroscience Institute (PNI) in 2005. The QNTP also
helped to inspire the formation (in 2008) of PNI's free-standing PhD Program in Neuroscience, which strongly
emphasizes classroom and laboratory training in basic quantitative and computational methods during its first
two years. These developments have made it possible for us to refocus the QNTP from its original purpose
(providing a foundation in quantitative neuroscience for trainees who are starting out in this area) to providing
advanced training in quantitative neuroscience. Specifically, we will take the most quantitatively-focused subset
of our predoctoral and postdoctoral trainees and provide them with the additional tools and training that they
need to excel in computational neuroscience research. This training will be accomplished via advanced
quantitative and computational neuroscience elective courses that were developed for the QNTP and are
taught by leaders in the field, as well as participation in research seminars, journal clubs, and career
development activities that are designed to deepen the trainees' knowledge and bolster community among the
trainees. PNI faculty have made seminal contributions to quantitative neuroscience, ranging from information-
theoretic analyses of neuronal spiking and dynamical systems analysis of decision-making to multivariate
decoding of human neuroimaging data. The QNTP has been specifically formulated to bring predoctoral and
postdoctoral trainees into contact with this expertise and, through this, to catalyze their transformation into full-
fledged computational neuroscientists. As with the prior funding period, we are requesting support for four
predoctoral trainees and four postdoctoral trainees (with 2 year appointments for each trainee).

Public health relevance
This is an application for support for advanced predoctoral and postdoctoral training in quantitative neuroscience. By instructing our trainees in computational modeling and advanced data analysis techniques, we aim to train scientists that will be able to bridge the key gap in our understanding of how the brain works: how do myriad single molecules and neurons collectively give rise to the mind? This is important for both basic science and clinical science - these modeling and data analysis techniques will give trainees a rich vocabulary and a powerful toolkit for exploring how pathologies of small-scale elements (e.g., deficits in neurotransmission at dopaminergic terminals) can lead to mental disorders (e.g., schizophrenia).